Wisconsin Allergy Research Training (WISCART) Program

DESCRIPTION (provided by applicant): The goal of the Wisconsin Allergy Research Training (WISCART) program is to provide research training for postdoctoral fellows in Allergy and Immunology to prepare trainees for careers as independent academic research scientists. Objectives to achieve this goal include 1) to establish a high quality and productive research project, 2) to develop a progressive record of publication in respected research journals, 3) to obtain extramural grant funding during the fellowship, and 4) to have a minimum of 50% of the graduates of this program pursue a career in Allergy and Immunology research. There are generally 6-8 Allergy/immunology fellows in the UW program, and 4 fellows supported by the WISCART program. All fellows are MDs who have completed residency training in either Pediatrics or Internal Medicine. The first year of the program is funded by monies provided by the departmental and divisional funds, and is primarily clinical in nature. After the clinical year, the second and third years (2 positions per year), which are research intensive, are funded by WISCART. Additional years of training are encouraged, and are funded by research grants or other sources. The WISCART trainers are a diverse group of clinical, translational and basic scientists, and there are an exceptional number of opportunities for trainee research projects. The curriculum takes advantage of a number of institutional resources, including the University of Wisconsin Institute of Clinical and Translational Research, to provide comprehensive clinical research training, and optional advanced degree programs in clinical research. RELEVANCE (See Instructions): Allergic diseases and asthma are among the most common diseases, and are increasing for reasons that are not well understood. The goal of this program is to provide training in clinical and translational research to physician scientists who wish to pursue careers devoted to research in these critical areas of unmet medical need.